Risk Factors and Prediction Modeling for Multiple Recurrences of Non-Muscle Invasive Bladder Cancer

Project Summary / Abstract
Bladder cancer (BCa) is the sixth most diagnosed cancer in the US, and the 10th ranked cancer in the world
posing a significant disease burden worldwide. The well-established risk factors for BCa are increasing age,
male sex, race/ethnicity, cigarette smoking, obesity, and several environmental and occupational exposures.
Of the estimated 600,000 newly diagnosed BCa cases each year worldwide, 70% to 75% are non-muscle-
invasive bladder cancers (NMIBC), a genetically and clinically distinct entity from muscle invasive tumors.
Although NMIBC have an excellent five-year survival rate (>95%), their recurrence rates are remarkably high
(40%-70%), leading to repeated treatments and follow-up clinic visits of patients with substantial healthcare
costs. Several clinical studies have examined associations of clinical and pathological features of NMIBC with
risk of recurrence, but results have been inconsistent. To-date little is known about epidemiological and clinical
risk factors for multiple recurrences of NMIBC.
The aims of the proposed study are: i) to examine the associations of demographic, lifestyle and social factors,
tumor characteristics (e.g. stage, grade, tumor size), comorbidities and cancer treatments with risks of first
and multiple (e.g. 2, ≥3) NMIBC recurrences and ii) to develop and validate risk prediction models for multiple
recurrences. The goal is to better understand the contribution of various epidemiological, lifestyle, and clinical
risk factors that could be used to identify which NMIBC patients are at the highest risk for multiple recurrences.
We will use existing demographic, lifestyle, social, clinical and tumor pathology data, cancer treatments and
recurrence events collected from two large cohorts of NMIBC patients: the Be-Well Study (N=1,472) within
the Kaiser Permanente healthcare system in California, US, and the BladderBaSe cohort of 38,547 patients
from Sweden. About 30% to 40% of patients have experienced multiple recurrences of NMIBC in each cohort.
Additional outcome events will be accrued with extended follow-up of both cohorts through 12/31/2024.
Results of this study will provide important new insights on the associations of various epidemiological and
lifestyle risk factors, clinical and tumor pathological data with risk of multiple recurrence of NMIBC in different
populations. This is a clinical research priority and an important next step in the development of individualized
patients care, targeted surveillance and clinical management of patients with NMIBC.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Of the estimated 600,000 newly diagnosed bladder cancer cases each year worldwide, 70 to 75% are non- muscle invasive tumors (NMIBC). The recurrence rates of NMIBC are remarkably high leading to repeated treatments and follow-up visits of patients with substantial healthcare costs. Understanding risk factors and developing risk prediction models for multiple recurrences of NMIBC in cancer patients is a clinical and research priority for surveillance and development of more refined, risk-stratified management algorithms.